Cutaneous opioid circuitry in skin inflammation and sensation

PROJECT SUMMARY/ABSTRACT
Inflammatory skin diseases such as atopic dermatitis and hidradenitis suppurativa are associated with
significant burdens of chronic itch and pain. Endogenous opioid peptides regulate these noxious sensations
and have critical homeostatic functions. While opioid biology research has predominantly focused on
pharmacology, much less is known about the endogenous opioid biology and circuits within the skin. My
preliminary data has identified the cellular sources of the endogenous opioid enkephalin and its function in
regulating skin inflammation and sensation. In this mentored career development plan, I aim to expand on my
previous and preliminary work to fill the knowledge gaps in cutaneous opioid circuitry and function.
In Aim 1, I propose to characterize the cutaneous sources of enkephalin and their somatosensory
functions in homeostasis and after inflammation. I hypothesize that regulatory T cell-derived enkephalin
will suppress allodynia, while keratinocyte-derived enkephalin will suppress itch after inflammation.
Additionally, I have identified the localization of the preferred receptor for enkephalin, the d elta opioid
receptor (δOR), and found that pharmacological or genetic inhibition of this receptor leads to height ened
allodynia and itch. In Aim 2, I will develop RNA-sequencing and in vivo calcium imaging methods for skin-
innervating sensory neurons to identify how δOR regulates sensory neuron identity and functional activity
in response to cutaneous stimuli. Finally, in Aim 3, I will assess whether genetic or pharmacological
modulation of the enkephalin-δOR circuit can influence cutaneous inflammation and itch in a murine
dermatitis model.
Under the guidance of Dr. Allan Basbaum, an authoritative expert in sensory neuroscience, and a
committee of multidisciplinary scientific leaders, I will leverage my immunological expertise to further my
long-term goal of becoming an independent physician-scientist. My scientific career will focus on defining
the signaling interface between the immune and nervous systems in cutaneous inflammation and sensory
perception. This proposal will enhance my skills in imaging, sequencing, sensory neuroscience and
signaling, allowing me to identify new targets for alleviating skin disease. This five -year career
development plan will provide comprehensive training in statistical analysis, scientific communication,
laboratory management and leadership, laying the groundwork for my future role as an independent
researcher contributing to our understanding of cutaneous biology.

Public health relevance
PROJECT NARRATIVE Endogenous opioid peptides regulate the cutaneous sensations of itch and pain and have critical homeostatic functions. My preliminary work implicates a role of opioid enkephalin circuit in regulating skin sensory and inflammatory function. In this proposal, I aim to define the precise mechanisms by which enkephalin regulates cutaneous inflammation and noxious sensation, with the ultimate goal of identifying therapeutic strategies for chronic inflammatory skin disease management.